Preclinical Assessment of Phage Therapy for Pathogen Decolonization

To 1) develop animal models for studying the use of bacteriophage therapy to decolonize or treat MRSA and VRE; and 2) use isolated phages and developed animal models to assess key regulatory questions surrounding the use of bacteriophage products.